SDQ Calibration Study

The purpose of this agreement is for the National Institute of Mental Health (NIMH) to provide $120,000 in FY2012 funds to the National Center for Health Statistics (NCHS). The FY2012 NIMH funds provide support for the National Health Interview Survey (NHIS) to conduct additional analyses and reports on the data collected for the SDQ Calibration Study; a follow-back study aimed at determining the best measurement cut points to accurately classify Serious Emotional Disturbance in children.